Cytek Aurora CS

PROJECT SUMMARY/ABSTRACT
Biomedical research is undergoing a revolution in single cell biology. Our ability to examine the proteome and
genome at the single cell level has never been greater. Thus, we have never had a greater need to isolate and
purify rare stem and progenitor cells, maturing organ-specific mesenchymal or epithelial cells, or novel immune
subsets. Long awaited computational advancements to fluorescence activated cell sorting now allow us to
capture and deconvolute the entire fluorescent spectrum of a fluorophore. This technology is revolutionizing our
ability to purify single rare cells. The instrument we are requesting is a Cytek Aurora CS and represents a major
breakthrough in flow cytometry that will remove the 8-12 color barrier that scientists have struggled with due to
bleed over of the spectra. This instrument is also intended as a supplement for aging instrumentation that is
close to the end of its service life and used beyond its expected capacity. The Aurora CS uses 64 channels of
fluorescent detection to sort single cells. This new technology will bring new challenges and still require robust
quality control protocols and knowledgeable professional personnel with a deep understanding of the electronics,
physics, and biology required to maximize this instrument’s usage and potential. The Vanderbilt Flow Cytometry
Shared Resource (VFCSR) is optimally configured to implement this instrument successfully and serves a broad
group of NIH funded scientists whose research Aims are dependent on flow cytometry measurements. Of key
importance, common fluorescent reagents, already used currently on our Cytek Aurora, can be used on this
platform. Custom reagents are not required, yet are still compatible. This instrument is capable of performing all
levels of cell sorting, from basic sorts to the upper limit of high-content flow cytometry. New reagents are in
development to maximize this instrument’s potential, currently estimated to be 45 color panels. VUMC maintains
an active administration and support infrastructure for the grant-funded projects of its investigators totaling nearly
$460M in research funding annually, and contributing to the majority of the School of Medicine NIH funding. This
instrument will greatly benefit investigators that require cell sorting while conducting cutting-edge research on
cancer, digestive diseases, immunology, infection biology, and immunotherapy. This instrument also will
enhance our ability to resolve and sort small particles like cellular vesicles and worm neurons, allowing us to
better serve our diverse research base in the region. The addition of this sorter, with its great flexibility and
fluorescent-parameter potential will be very impactful for Vanderbilt scientists. The capability to generate more
valuable data per sample and per cell, will enhance the ability of the Vanderbilt research community to make
break-through discoveries for the advancement of science and medicine.

Public health relevance
PROJECT NARRATIVE Replacing the BD FACSAriaIII cell sorter with a Cytek Aurora CS is crucial to continuing the momentum of the revolution in single cell biology at Vanderbilt. Addressing the disconsolation of the BD FACSAria instruments by replacing aging technology with a more robust and capable Cytek Aurora CS will enable the single cell analysis of rare stem, progenitor, mesenchymal, and epithelial cell populations or immune subsets, without disrupting the steady and routine purifications that have led to transformative discoveries. Most importantly, this investment will impact multiple NIH institutes and accelerate discoveries across the Vanderbilt campus and the return on this investment will be roughly 10-fold within the first three years of installation.